Molecular mechanisms of hypervirulence in antibiotic-resistant Pseudomonas aeruginosa

PROJECT SUMMARY/ABSTRACT
Antibiotic resistance is a major healthcare problem because it renders treatment ineffective, leading to chronic
infections and death. Pseudomonas aeruginosa (PSA) is notorious for its capacity to mutate and become
antibiotic resistant during chronic infections. Evolutionary theory predicts that these mutations will lead to
fitness defects, including decreased growth rates that reduce the resistant organism’s ability to survive
competition with wild-type susceptible siblings when antibiotic treatment ends. Moreover, fitness costs could
also reduce virulence by reducing the resistant population’s ability to replicate fast enough to overcome killing
by the host immune response. In reality, these predictions are frequently contradicted: antibiotic resistant PSA
are readily isolated alongside susceptible siblings during decades-long chronic infections, and recently we
discovered that antibiotic resistance mutations that increase efflux pump expression can also increase PSA
virulence even in the absence of antibiotics. However, the conditions that enable resistant bacteria to compete
with susceptible bacteria are unknown and the mechanisms by which resistance mutations increase virulence
are unclear. The central hypothesis of this proposal is that mutation of efflux pump components leads to
increased virulence in antibiotic resistant strains. The three specific aims of this proposal are to
1) determine the role of quorum sensing in enhanced virulence of aztreonam resistant PSA,
2) determine fitness of aztreonam resistant mutants relative to wild-type PSA, and 3) identify novel
therapeutic targets in aztreonam-resistant PSA. In our previous work, both hypervirulent resistant PSA
strains had resistance mutations that functioned by increasing mexAB-oprM antibiotic efflux pump expression.
In addition to its role exporting antibiotics, MexAB-OprM also secretes a PSA quorum sensing molecule which
is involved in regulating several virulence factors. In preliminary experiments, hypervirulent resistant PSA
increased swarming and biofilm phenotypes, which are both mediated by the bacterial quorum sensing
regulated virulence factor rhamnolipid. In the first aim of this proposal we will test the hypothesis that increased
virulence of resistant PSA is due to increased quorum sensing regulated rhamnolipid production. In the second
aim, we will test the hypothesis that specific nutrients, stresses, or host cells enable resistant bacteria to
compete with susceptible bacteria. In the third aim, we will test the hypothesis that targeted therapies against
hypervirulent resistant PSA will reduce virulence and improve clearance during infection, and we will use
random transposon mutagenesis in combination with next-generation sequencing to identify new drug targets
in antibiotic resistant PSA. These studies will help us understand how antibiotic resistant bacteria can arise
during infection, as well as how we can leverage this knowledge and translate it into desperately needed
therapies for antibiotic resistant bacteria.

Public health relevance
PROJECT NARRATIVE Antibiotic development has stalled during a time when antibiotic resistant bacteria are becoming increasingly more prevalent and dangerous to human health. We recently found that some antibiotic resistant bacteria also become deadlier as a result of their antibiotic resistance, even when antibiotics are not being used to treat the infection. The goals of this research are to determine why antibiotic resistant bacteria are deadlier than antibiotic susceptible bacteria and to leverage this information for the development of new therapies to treat antibiotic resistant bacteria.